CCOP Research Base, PCPT/PCPT LTFU, and SELECT Programs

[unreadable] DESCRIPTION (provided by applicant): It is noted that the applicant has not provided description as requested (PHS 398, Form Page 2). [unreadable] [unreadable] [unreadable]